Bioinformatics Core

PROJECT SUMMARY/ABSTRCT – Bioinformatics Core The SC INBRE Bioinformatics Core uses a variety of approaches to promote Bioinformatics across the SC INBRE Network: The Core provides support for library services to the PUI faculty; it provides training, both in the form of didactic courses that can be shares across institutions, and as guided site visits to core facilities; workshops; summer undergraduate training; graduate student training; and training of postdoctoral fellows. The Bioinformatics Core directly supports research and the application of Bioinformatics approaches to biomedical questions, by supporting the Bioinformatics Pilot Project Program, and by providing direct assistance to faculty for the preparation of grant applications, from experimental design to letters of support. The Bioinformatics Core and affiliated facilities provide genomics and proteomics services, data analysis tool and data storage facilities. Last, but not least, the Bioinformatics Core promotes communication across the network by organizing seminars, site visits to network institutions, and symposia. In the next phase of SC INBRE the Bioinformatics Core will continue and expand those activities, doubling the support to the USC School of Medicine Library in order to provide access to electronic library resources to PUI faculty in the expanded SC INBRE III Network. The Core will also expand the Bioinformatics Pilot Project Program, bringing the number of awards made every year from 4-5 to 10. The Core will continue to train undergraduate students, graduate students and postdoctoral fellows, promoting interactions and collaborations by the adoption of WebEx, which allows for meetings to be held electronically with a large number of participant. By utilizing WebEx, the Core will organize regular meetings of the pilot project recipients and their students; workshops; training sessions (with groups or one-on-one); and seminars that will help increase the networking aspects of the Pilot Project program within SC INBRE. The Core will also continue to develop and share Bioinformatics tools, particularly in the areas of next-gen sequencing data analysis, and modeling of protein structure.

Public health relevance
PROJECT NARRATIVE – Bioinformatics Core As a discipline, Bioinformatics is at the leading edge of modern Biomedical Science, and the development of skills in this area is a vital component of the training of life scientists, therefore the Bioinformatics Core is an indispensable component of the SC INBRE Network and strongly contributes to attaining SC INBRE goals. The SC INBRE Bioinformatics Core uses a variety of approaches to promote Bioinformatics across the SC INBRE Network, providing access to library services to PUI faculty; training of undergraduate students, graduate students and postdoctoral fellows. The Bioinformatics Core supports research and the application of Bioinformatics approaches to biomedical questions with a Pilot Project Program, and by providing direct assistance to faculty for the preparation of grant applications; the core provides genomics and proteomics services, data analysis tools and data storage facilities. The Core develops and shares Bioinformatics tools, particularly in the areas of next-gen sequencing data analysis and modeling of protein structure.